Tumor evolution and intratumor heterogeneity

This project aims to develop next generation computational methods for the integrative analysis of single cell, bulk whole genome or transcriptome, or spatial transcriptome sequencing data, both through short and long read technologies for understanding how tumors emerge and progress through mutational acquisition across generations of cancer cells. We use combinatorial optimization and machine learning techniques to not only infer tumor progression trees but also computational means to integrate them with other data types and validate their implied conclusions.